Administrative Core

The Administrative Core of the P01,

Public health relevance
RELEVANCE (See instructions): The work will have a significant impact on influenza vaccine development and for immunization against other pathogens with rapid antigenic variation. The project will also lead to a greatly improved understanding of the human immune response to vaccines and to the implementation of novel structural methods in virology and immunology.